Transposable Element Interaction and Its Impact on Human Development and Health

Summary of Parent Award
This is a proposed supplement to Dr. Bo Xia’s NIH Director’s Early Independence Award
(DP5OD033430) titled: “Transposable Element Interaction and Its Impact on Human Development
and Health”. Below is the abstract of this parent award:
One of the most surprising discoveries from the Human Genome Project is that only about
1.5% of the genome codes for proteins, whereas around 46% comprises transposable elements
(TEs). Functional assessment of how these ubiquitous TEs affect human development and health has
posed a major challenge. While most TEs are considered non-functional, or “junk” DNA, here I argue
that TE-induced gene regulation is strongly underestimated due to the historical tendency to explore
TE functionality by studying individual TEs independently of each other. I propose to provide a novel
framework to study how interactions between the hitherto “junk” TE sequences can regulate pre-
mRNA splicing to affect gene function, and investigate whether such a mechanism could substantially
affect both human development and evolution, and help explain the genetic etiology of human
diseases. This proposal is inspired from my recent discovery that the interaction between a pair of Alu
retrotransposons may explain the long-sought genetic basis for the evolution of tail loss in human and
apes. Based on this work and my preliminary data, I will first use the Alu pair interaction in TBXT gene
as a model to demonstrate that the interaction between intronic TEs can profoundly impact human
development and health, and explain the etiology of a common genetic disease (Aim 1). Aim 2
proposes to test the hypothesis that the isoform of TBXT induced by interaction of the Alu pair
pleiotropically contributes to strengthening of hindlimbs, thus directly testing the long-standing
hypothesis that the tail-loss evolution in hominoids is associated with bipedal locomotion evolution
(Aim 2). Beyond the specific interaction of the Alu pair in the TBXT gene, Aim 3 will develop an
algorithm called TEILO (Transposable Element Interaction & Local Organization) to systematically
identify the functional TE interactions that affect gene function and human health by modulating
alternative splicing. This work premises a new paradigm to studying the interaction between TEs and
its implication to human health and diseases.

Public health relevance
PROJECT NARRATIVE Functional assessment of how the ubiquitous transposable elements (TEs) affect human development and health has posed a major challenge. This proposal aims to provide a novel framework to study how interactions between the hitherto “junk” TE sequences can regulate pre-mRNA splicing to affect gene function, and argues that such a mechanism can substantially affect both human development and evolution, and help explain the genetic etiology of human diseases.